Clustering of Rehospitalization Risk Factors and Identification of Associated Home Health Interventions in Aging Sepsis Survivors Receiving Home Healthcare

Project Summary
This F99/K00 Transition to Aging Research for Predoctoral Student Award application will support the
applicant’s research training to become an independent researcher focused on improving outcomes for older
sepsis survivors with complex needs transitioning from hospital to home healthcare (HH) using advanced data
science methods. The study aims to understand complex associations of coexisting rehospitalization risk
factors (including social support, personal, and contextual factors) with rehospitalization among older sepsis
survivors and to identify specific HH interventions that improve care quality and outcomes.
In the F99 phase, the applicant will (1) describe distinct and shared profiles of clusters among older sepsis
survivors with coexisting rehospitalization risk factors and (2) examine the associations between these clusters
and rehospitalization. This retrospective cohort study will use existing national Medicare claims data to identify
HH patients aged 65+ with a sepsis diagnosis during an inpatient stay. In the K00 phase, the applicant will
build on F99 findings by validating the clustering algorithm with a new, unseen sample and expanding training
for the applicant in natural language processing (NLP) to analyze clinical notes by (1) developing an NLP
algorithm to identify HH interventions, (2) describing differences in HH interventions across distinct clusters,
and (3) assessing the association between identified HH interventions and rehospitalization.
Research training will take place at two research-intensive institutions, the University of Pennsylvania (F99)
and Columbia University (K00), with ample resources and support from a multidisciplinary mentorship team
with expertise in aging, sepsis survivorship, transitions in care, multimorbidity (i.e., multiple chronic conditions
or clinical conditions), machine learning, NLP, and quantitative statistics. The training plan includes
coursework, practical training, research meetings, seminars, professional and career development, and
research dissemination skills. Training will focus on conceptual knowledge (e.g., sepsis survivorship, aging,
multimorbidity), methodological skills (e.g., clustering, NLP), rigorous and ethical research conduct, and
professional development. To ensure a smooth transition from F99 to K00 to independence, the applicant will
acquire the foundational knowledge for each phase.
This proposal aligns with the priorities of the National Institute on Aging to understand multilevel aging
factors and develop efficacious, cost-effective strategies for older adults. The findings of these proposed
studies will provide insights into designing, testing, and implementing cluster-specific care pathways for the
growing population of older sepsis survivors.

Public health relevance
Project Narrative Millions of older adults with multimorbidity experience sepsis and are at risk for high rehospitalization risks, yet the complex needs of older sepsis survivors in home healthcare (HH) remain poorly understood, especially with coexisting rehospitalization risk factors. This proposal examines associations between risk factor clusters and rehospitalization outcomes (F99) and identifies HH interventions associated with lower rehospitalization (K00). Findings will inform the development of cluster-specific care pathways to improve care quality and outcomes for the vulnerable and growing population of older sepsis survivors.